Detecting RORgt Citrullination

Project Summary
Many proteins are modified after they are produced in cells. Such modification can critically influence the
function of proteins. One such modification is citrullination, which has been shown to regulate the function of
immune cells, including lymphocytes and neutrophils. Abnormal citrullination has been associated with many
human diseases, including infection and autoimmune diseases. Thus, manipulating protein citrullination can be
beneficial in many clinical settings; however, our knowledge of citrullination is still very limited mainly due to
lack of sensitive and specific tool for detecting citrullination. The objectives of this project are to develop a
reagent that can reliably detect the citrullination of a protein named RORgt, which is important for the
differentiation/function of lymphocytes, and to demonstrate the value of this reagent in a proof-of-principle
experiment. The reagent thus generated will be a powerful tool for future studies on the regulatory roles of
citrullination in the function of lymphocytes and very likely will lead to discoveries of novel therapeutic targets of
human diseases.

Public health relevance
Project Narrative Many proteins are modified after they are produced in cells. One form of protein modification called citrullination is important for body's defense against invading microbia and also for proper function of cells. Developing a sensitive and specific reagent that can detect the citrullination of any given protein will markedly advance our understanding of how citrullination is regulated and how it affects the function of human cells, and will uncover novel strategies of improving human health.